Conduct of studies to evaluate the toxicity and carcinogenicity of multiwalled carbon nanotubes in laboratory animals for the National Toxicology Program (NTP)

The goal of this project is to characterize the chronic toxicity and carcinogenicity of multiwalled carbon nanotubes (MWCNT). MWCNT have a wide variety of industrial applications and the use is increasing rapidly. Two-year studies, which include prechronic interim necropsies and immunotoxicity evaluations are in the prestart chemistry/exposure phase. Keywords: toxicity, carcinogenicity, inhalation, multiwalled carbon nanotubes, nanotechnology